Comp B National Spina Bifida Patient Registry at Vanderbilt Children's Hospital Component

PROJECT SUMMARY
Advances in medical care have increased longevity for babies born with spina bifida, the most common
permanently disabling birth defect in the United States. However, long-term health outcomes are limited, practice
patterns vary, and best practices are not well defined. The Spina Bifida Program at Monroe Carell Jr. Children's
Hospital at Vanderbilt (MCJCHV) evaluates over 250 patients with spina bifida each year. The neurosurgery,
orthopaedics, and urology programs at MCJCHV have set the following goals for this study: 1) to approach each
eligible patient in our program for enrollment, 2) to contribute longitudinal data on health status, clinical care, and
outcomes for consented patients to the NSBPR over the five year study period, and 3) to evaluate NSBPR data
to answer hypothesis-driven questions about outcomes in spina bifida. The PI along with the clinical research
coordinator will ensure quality control of data submitted to the CDC. The PI and the Spina Bifida Program have
a demonstrated record of productive research with the NSBPR and other national databases. Published results
from this study will help to inform best practice clinical guidelines for spina bifida.

Public health relevance
PROJECT NARRATIVE Although spina bifida is the most common permanently disabling birth defect in the United States, long-term medical outcomes are limited, and best treatment throughout the person's lifetime is not well defined. The Spina Bifida Program at Monroe Carell Jr. Children's Hospital at Vanderbilt sees a large population of pediatric spina bifida patients. By contributing our data to the CDC National Spina Bifida Patient Registry (NSBPR) and by using the registry to answer questions about best and most efficient treatment, we hope to improve both health care utilization and outcomes for spina bifida patients.